Polycystins, cilia, and extracellular vesicles in C. elegans

Project Summary
Autosomal dominant polycystic kidney disease (ADPKD) is a common, life threatening disease that affects 1/400-1/1000 individuals. ADPKD is caused by mutations in PKD1 and PKD2, which encode polycystin-1 and polycystin-2 (PC1 and PC2). In the model organism C. elegans and humans, the polycystins LOV- 1/PC1 and PKD-2/PC2 are architecturally similar, act in the same genetic pathway, function in a sensory capacity, localize to primary/sensory cilia, and are shed in tiny extracellular vesicles, suggesting ancient conservation. Moreover, ciliary EV biogenesis and shedding is an evolutionary conserved process from algae to worms to humans. While cilia and EVs are of profound medical importance, the field lacks a basic understanding of how EVs form, what cargo is packaged in different types of EVs originating from different cell types, and how different cargoes impact EV bioactivity signaling. The model system C. elegans has consistently driven discovery in biomedical research. For example, C. elegans provided one of the first links between cilia, polycystic kidney disease, and ciliopathies. This competing renewal application will bring to bear the power of the C. elegans system combined with multi-color super resolution microscopy and real time imaging of fluorescent-protein tagged PKD-2 and LOV-1 EV cargoes and in vivo readouts of ciliary EV bioactivity. This innovative approach will be used to tackle major challenges and questions in the field of PKD biology and to discern the roles of the polycystins on cilia versus ciliary EVs. These studies will have significant impact on the understanding of human ciliopathies like ADPKD, in which cilia and potentially EVs play important roles.

Public health relevance
Project Narrative Autosomal dominant polycystic kidney disease (ADPKD) is a common, life threatening disease that affects 1/400-1/1000 individuals. ADPKD is caused by mutations in PKD1 and PKD2, which encode polycystin-1 and polycystin-2 (PC1 and PC2). In the model organism C. elegans and humans, the polycystins LOV- 1/PC1 and PKD-2/PC2 are architecturally similar, act in the same genetic pathway, function in a sensory capacity, localize to primary/sensory cilia, and are shed in tiny extracellular vesicles, suggesting ancient conservation. This competing renewal application will tackle major challenges and questions in the field of PKD biology and to discern the roles of the polycystins on cilia versus ciliary EVs.